SWG 10: Health Equity

Project Summary/Abstract
Structural and institutional discrimination create inequities in opportunities and resources needed for HIV
prevention and treatment, contributing to pervasive HIV disparities in key populations, which have persisted
since the early years of the HIV epidemic. As individuals with marginalized identities encounter significant
barriers to accessing HIV-related services due to the intersectional nature of systemic discrimination, bias, and
racism in the US and globally, there is an evident need for increased research and attention on addressing HIV
related disparities in historically disadvantaged groups. The proposed Health Equity Scientific Working Group
(SWG) will catalyze efforts to investigate and understand the complex social and structural determinants of
health disparities and to promote innovative research to attain health equity and remove sources of unfair health
differences among historically marginalized populations. Our Steering Committee and the CFAR EDI Director
will help to guide our work. Our Specific Aims are to: 1) Create a hub for community-engaged,
interdisciplinary collaborations that will generate key data and conduct analyses that elucidate
characteristics of HIV-related health disparities; 2) Promote and support interdisciplinary teams that
include community partners and academic researchers to develop research agendas that advance
community-engaged, health equity-focused HIV research at our CFAR; and 3) Develop research
proposals that advance the achievement of health equity in HIV prevention and treatment among health-
disparities populations with attention to the Pacific Northwest region. For Aim 1, we will conduct monthly
works-in-progress meetings that will convene a multidisciplinary group of researchers, including early career and
underrepresented individuals, to facilitate collaborations that will contribute to data generation and analyses that
elucidate characteristics of HIV-related health disparities. For Aim 2, we will convene community meet and
greets developed in partnership with the UW/FH CFAR Office of Community Engagement (OCE) to foster
collaborations for researchers and community members to develop health-equity related research projects. For
Aim 3, guest speakers will provide expert perspectives on select health equity-related research topics to support
development of successful research proposals that will advance the achievement of health equity in HIV
prevention and treatment. The Health Equity SWG presents an important opportunity to bring established and
new investigators and community members together to strengthen and promote equity-focused research
programs and provide scientific leadership in the area of health equity. The SWG will contribute to the strengths
and interdisciplinary expertise of the UW/FH CFAR through its integration of community partnerships and
multidisciplinary collaborations. Through the proposed activities, the SWG will expand current research
approaches to build upon what we know about health disparities to eliminate barriers to achieving equity in
access and utilization of HIV prevention and care.